Optimizing Acquisition and Reconstruction of Under-sampled MRI for Signal Detection

PROJECT SUMMARY
Magnetic resonance imaging (MRI) is a versatile imaging modality that suffers from slow
acquisition times, which is a challenge, for both time sensitive applications and for patient
throughput. Accelerating MRI would benefit patients both by reducing the time they need to
be in the scanner and in reducing the cost of healthcare. This project is part of a larger
scientific effort to accelerate MRI while maintaining the diagnostic quality. Acceleration, even
by a factor of two, would result in a major advance for public health. Two of the current
approaches to accelerate MRI rely on collecting less data (under-sampling) and deep learning
reconstruction. These approaches can lead to images with diagnostic quality using significant
under-sampling but may suffer from artifacts which are hard to characterize and may
sometimes resemble anatomy. Specifically, this project will optimize the performance
of accelerated MRI, including undersampling patterns and deep learning
reconstructions, on detecting and localizing subtle lesions. To carry out this
optimization, we will first develop the methods required for detection of lesions by machine
and human observer models. The human observer models will be validated by
psychophysical studies where humans perform the detection task. In the first aim of this
project, we will apply and develop detection tasks and model observers. We will consider
under-sampled acquisition strategies in MRI including one and two-dimensional subsampling
methods using deep learning reconstructions which enforce data consistency. We will
develop detection tasks for signals in anatomical backgrounds were the signal location is
known and when the observer needs to search for the signal. The human and machine
performance in these tasks will be modeled. In the second aim, we will optimize data
acquisition and neural network reconstruction using signal detection with observer models
and psychophysical experiments. We will also introduce a detectability-based loss function
to neural network reconstructions. There is recent interest in exploring the benefits of low/mid
field MRI which has a trade-off with higher noise. In the third aim, we will evaluate the effect
of field strength on signal detection. We will use data from high field acquisitions from a
publicly available database to model images from lower magnetic fields. Using the detection
of subtle lesions, we will evaluate detection performance with varying field strength. This
research project will help to strengthen the research environment and broaden participation
at Manhattan College by involving students in biomedical research incorporating applied
mathematics, statistics and data science.

Public health relevance
PROJECT NARRATIVE Magnetic resonance imaging (MRI) is a versatile imaging modality that suffers from slow acquisition times, which is a challenge, for both time sensitive applications and for patient throughput. Accelerating MRI would benefit patients and improve public health both by reducing the time they need to be in the scanner and in reducing the cost of healthcare. This project would advance the larger scientific effort to accelerate MRI while maintaining the diagnostic quality by optimizing the performance of deep learning reconstruction on detecting and localizing subtle lesions.